Lysosomal Enzymes in Outflow Pathway Physiology and Pathophysiology

SUMMARY Defective aqueous humor (AH) drainage through the trabecular meshwork (TM) / Schlemm's cannal (SC) conventional outflow pathway is usually associated to elevated intraocular pressure (IOP), and hence, increased risk for developing glaucoma, a blinding disease second leading cause of permanent blindness in the US. The nature of such resistance to AH outflow is far from being elucidated. The TM consists of sheets of connective tissue beams lined by TM endothelial cells. Each beam is composed of a central elastic core surrounded by collagen fibers embedded in a ground substance. The glaucomatous outflow pathway is characterized by thickening of the trabecular lamellae and accumulation of long-spacing collagen bundles and elastic fiber sheaths, which is presumed to stiffen the TM and prevent the tissue to respond to mechanical cues. The exact causes underlying the deposit of extracellular material (ECM) and thickening of the beams remain unknown; but it is likely a consequence of excessive synthesis of ECM components, decreased proteolytic degradation, or both. Matrix metalloproteinases (MMPs) have been historically believed to be the major proteases involved in ECM degradation; however, emerging evidence indicates that while MMPs play a critical role in initiating ECM degradation in the extracellular environment, other proteases or the coordinated action of several types of proteases (i.e. cysteine and serine proteases) are responsible for the bulk matrix degradation, occurring pericellularly and intracellularly in the lysosomal compartment, associated to lysosomal cathepsins. In agreement, studies conducted in our laboratory have clearly demonstrated the constitutive cell surface expression and secretion of cathepsin B (CTSB) in TM cells and its participation in the endocytic uptake and intralysosomal degradation of native and denature collagens. Here we propose to investigate for the first time the contribution of a CTSB-mediated pericellular and intracellular ECM degradative pathway in TM cells and the effect on outflow physiology. We hypothesize that CTSB plays a critical role in ECM remodeling and outflow physiology by initiating a proteolytic cascade leading to the pericellular and intracellular degradation of ECM components in TM cells. We further hypothesize that modulation of CTSB activity may represent a novel therapeutic strategy in glaucoma. To test this hypothesis, we will (1) demonstrate that CTSB associates with caveolae and initiates a proteolytic cascade resulting in the partial degradation of ECM components; (2) determine the cell surface receptors participating in of ECM components in TM cells; and (3) evaluate the effects of modulating CTSB activity in outflow pathway function of murine glaucoma models.

Public health relevance
PROJECT NARRATIVE The trabecular meshwork in glaucoma is characterized by abnormal increase deposition of extracellular material in the outflow channels and within the beams. The objective of this new grant proposal is to investigate a novel cellular mechanism not studied in the trabecular meshwork tissue that could help to the degradation of this material. That being the case, pharmacological modulation of this cellular pathway could then constitute a novel therapeutic strategy for glaucoma.